Technology Transfer

The Office of Technology Transfer and Innovation Access (OTTIA) provides services supporting the National Institute of Dental and Craniofacial Research (NIDCR)'s transactional agreement activities through the NIDDK TAO Service Center. OTTIA broadens the impact of NIDCR intramural research by fostering scientific exchange, promoting NIDCR research, and obtaining material and financial resources. Agreements facilitate: *exchanges of research materials under the Material Transfer Agreements (MTAs); *collaborative research conducted under cooperative research and development agreements (CRADAs); *clinical studies to determine the safety and efficacy of new agents and devices under clinical CRADAs; *exchanges of confidential information or data under confidential disclosure and data sharing agreements (CDAs, DSAs); and IN FY2021, the TAO Service Center completed 1 Advisory agreement, 5 CDAs, 2 DTAs transfer agreements, 2 CRADA amendments, 2 Research Collaboration Agreements, 4 licenses or license amendments, and processed 1 Employee Invention Reports. Additionally, Addgene facilitated execution of 47 MTAs on NIDCR's behalf.